NRSA Training Core

Contact PD/PI: Brasier, Allan NRSA-Training-001 (003)
NRSA TL1 TRAINING PROGRAM ABSTRACT. The central goal of the Institute for Clinical and Translational
Research (ICTR) TL1 Training Program is to contribute to translational workforce development by preparing a
robust cohort of scholars that can address societal health needs through clinical and translational research
(CTR) endeavors in academia, government, and industry. The University of Wisconsin-Madison (UW) TL1
Training Program has been active since 2008, and currently supports both predoctoral and postdoctoral
scholars for two-year appointments. The objectives for the upcoming funding period are to: 1) Augment our
current success in building capacity of the translational workforce via predoctoral and postdoctoral training; 2)
Innovate our tailored, competency-based TL1 curriculum to provide the flexibility and adaptability to realize the
“Wisconsin Idea” in the context of a continually shifting research landscape; 3) Advance inclusive excellence
by intentionally enhancing translational workforce diversity and expanding the health equity research portfolio;
and 4) Instill trainees with the team science and leadership skills to work effectively in interdisciplinary teams.
We will address these objectives by providing more flexible curricular options in the areas of community
outreach, bioinformatics, science communication, and entrepreneurship; by enhancing experiential learning
opportunities through biotechnology externships in partnership with UW’s Forward BIO Innovators in Training
program; by broadening diversity by partnering with the UW Faculty Diversity Initiative, by participating in the
National Research Mentoring Network’s Building Up program, by embracing a new Equitable Translational
Research and Innovation scholars program; and by promoting inter-hub collaboration and team science
initiatives by instituting an annual Midwest TL1 Research Summit. We are requesting support for 11
predoctoral and four postdoctoral scholars in the upcoming period. All scholars will receive didactic training in
core translational research skills, the responsible conduct of research, rigor and reproducibility, mentor/mentee
strategies, and team science skills. We will evaluate the success of our program guided by the ICTR
Innovation Scorecard and measure impact using the Translational Sciences Benefits Model. We will use mixed
qualitative and quantitative methods, including monitoring scholar progress along individual development plans
and self-efficacy in key National Center for Advancing Translational Sciences CTR competencies; tracking
scholar productivity and career milestones; surveying scholar satisfation with training opportunities; and
continually assessing our scholar cohorts and project portfolios to advance workforce diversity and health
equity. This innovative TL1 programming, including mentorship, team science, and health equity, in an
environment of inclusive excellence, will foster and launch a cadre of diverse, independently funded leaders of
CTR who will impact the health of our patients, families, and communities.